Beta-Lactam Resistance Mechanisms of Staphylococcus aureus

Project Summary/Abstract
Staphylococcus aureus is a problematic human bacterial pathogen, which is broadly resistant to b-lactam
antibiotics. This resistance is inducible and is conferred by a set of genes that encode a b-lactam antibiotic
sensor/signal transducer protein, a gene repressor and two resistance determinants (the BlaZ b-lactamase and
a unique penicillin-binding protein designated as PBP2a). A key feature of these processes is the recognition
of the antibiotic by the b-lactam sensor/signal transduce BlaR, an integral membrane protein. Recognition of
the antibiotic by the sensor domain of BlaR unleashes conformational changes through the membrane, which
lead to the activation of the protease domain on the cytoplasmic side. This process culminates in expression of
the genes for the antibiotic-resistance determinants. In Specific Aim 1, we describe the use of a fluorescent
tool in live S. aureus for discovery of agents that shut down the BlaR recognition of the b-lactam antibiotics,
which would reverse the resistance phenotype. A discovery funnel is outlined for analysis of structure-activity
relationship for these compounds. In Specific Aim 2 we communicate a discovery that the BlaZ b-lactamase is
incorporated to the surface of the cytoplasmic membrane in a lipidation- and phosphorylation-dependent
manner. We outline a method for purification of the membrane-anchored BlaZ for the purpose of the
identification of the sites of phosphorylation. The protein will be used in kinetic studies to compare to the non-
membrane-anchored BlaZ, which is not phosphorylated. Plans are detailed for X-ray crystallography for
characterization of the structural issues. The generality of the lipidation- and phosphorylation-dependent
anchoring of proteins to the membrane surface in S. aureus will be explored for 10 distinct proteins. In each
case, plans are outlined to identify the sites of phosphorylation to elucidate rules for phosphorylation and
membrane sequestration of these proteins. These studies will shed definitive light on the complex machinery
that S. aureus strains have evolved for resistance to b-lactam antibiotics.

Public health relevance
Project Narrative Staphylococcus aureus is an important human bacterial pathogen, which is responsible for significant mortality and morbidity on an annual basis. b-Lactam antibiotics have been preferred for treatment of S. aureus infections over the years, however rampant global resistance to these versatile drugs has resulted in obsolescence of many antibacterial mainstays. We investigate in this grant application the complex machinery that results in b-lactam antibiotic resistance in S. aureus. We also seek novel antibiotics and adjuvant agents that have the ability to reverse the b-lactam-resistance trait, bringing back from obsolescence b-lactam antibiotics for treatment of this problematic bacterium.